Pilot Project Program

ABSTRACT
The Pilot Project Program is an integral part of the EDGE Center, providing initial support for investigators to
establish novel lines of research relevant to the missions of the NIEHS and the EDGE Center. The program
promotes exploration of possible innovative directions representing a significant departure from on-going
funded research for investigators in environmental health sciences. Investigators from other areas of focus are
also encouraged to apply their expertise to environmental health research. The pilot project grants are
designed to assist investigators in obtaining preliminary data that will be useful for competitive, full-scale grant
applications in the area of gene-environment interaction (GxE). The Center especially encourages applications
that focus on the role of human genetic and epigenetic variation as modifiers of environmentally induced
diseases. These grants may also focus on research-based community outreach activities. The EDGE Pilot
Projects Program serves as a great tool to foster new and interesting hypotheses that aim to fill gaps in EHS
research, especially in relation to environmental exposures, mechanistic toxicology and gene-environment
interactions. The Center is committed to providing invaluable support in launching the careers of a number of
promising young scientists through the Pilot Projects Program. Therefore, the program will favor the
applications of junior EHS faculty members and utilize this program to augment their Career Development.
This program has and will continue to be imperative to the interconnectedness and success of the Center as a
whole.